Precision Medicine Center for Cystic Fibrosis

ABSTRACT/PROJECT SUMMARY (CLINICAL PHENOTYPING CORE – CORE 3)
The Clinical Phenotyping Core (Core 3) has a single overarching goal: to facilitate rapid translation of basic
science research/pre-clinical work to human cystic fibrosis (CF), CF carrier, and non-CF (control) subjects and
samples. The Core was established to address two major limitations: 1) knowledge gaps in in relating basic
science to clinical human subjects’ data and 2) access of basic scientists to human samples. Together these
core issues create a major barrier to translation of basic findings (especially disease pathophysiology) to humans
with CF. The Core supports rapid translation of basic CF research by providing CF investigators access to both
banked and prospectively acquired human biospecimens through the following three aims: (1) Proactively
facilitate the recruitment of CF, carrier, and non-CF subjects to investigator-driven clinical trials. The
Core assists basic and translational researchers in obtaining specific biological samples that are not routinely
banked and it aids in conducting clinical trials, including clinical study design and statistical support, preparing
IRB submissions, recruiting participants, performing specialized procedures, and ensuring that clinical research
is conducted in accordance with the principles of Good Clinical Practice (GCP). (2) Organize, maintain, and
support an electronic and physical biobank of CF, carrier, and non-CF human specimens collected
during routine clinical visits and clinical trials. The Core provides and supports a centralized database of
CF, carrier, and non-CF bio samples, and prospectively archives biosamples of general utility to investigators
performing clinical/translational research. The Core obtains and maintains active consent for sample biobanking
from people with CF (pwCF), people with CF-associated symptoms not currently diagnosed; acquires and
maintains CF and non-CF specimens including DNA, bronchoalveolar lavage fluid (BALF), sputum, whole blood,
plasma, serum, feces, urine, tissue from surgical and autopsy samples, and bacterial isolates, (including
molecular typing of bacterial and other isolates when available); maintains databases of historical clinical
samples and prospectively collected samples; and maintains and improves a standardized process through
which investigators can obtain de-identified or identified clinical information from archived clinical samples or
samples obtained prospectively during routine clinical bloodwork. (3) Provide a portal through which
investigators can obtain clinical information on archived and prospectively collected biosamples. The
Core assists investigators in obtaining de-identified clinical information (or identifiable information as approved
by the IRB) from CF, carrier, and non-CF human subjects, including both subjects with extant samples in the
biobank and subjects whose samples require prospective collection. Information from ongoing clinical trials within
the Center, or supporting unique research needs, may be provided as needed with appropriate IRB approval.
The biobank has standardized consent in place for >70% of people who are seen for CF at UI, and thus facilitates
rapid investigator access to samples and linked clinical information.